PHS2019-02 Omnibus Solic of the NIH, CDC, and FDA for SBIR Apps No Clinical Trial (Parent SBIR R43/4

Field Detection of arboviruses directly from mosquito traps
Firebird Biomolecular Sciences, LLC.
Abstract
Mosquitoes are the world's deadliest creatures. In the US, mosquitoes are vectors for West Nile, many kinds
of encephalitis, and viruses arriving Latin America and Africa. In the developing world, they cause millions of
cases of disease and death each year. Routine insect spraying is not a "fix", as it leads to pesticide resistance,
encounters public opposition, and destroys beneficial insects. Thus, the EPA, CDC, ECDPC, and their
counterparts around the globe, strongly recommend surveillance before spraying. Florida law requires it.
In Phase 1, we created (a) innovative technology to generate CO2 to attract mosquitoes, (b) innovative tech-
nology to collect viral RNA from the attracted mosquitoes, (c) data showing that collected RNA is stable under
Florida summer conditions for at least 3 days, (d) processes where captured viral RNA is amplified directly
without handling mosquitos or Qiagen RNA preps, and (e) reagents that allow robust multiplex amplification.
These specs, which can transform the science and practice of arbovirus surveillance, attracted TrakITNow, an
innovator in instrument design. Its award-winning trap (Moskeet) counts and speciates mosquitoes, doing
everything short of collecting samples from the mosquitoes and determining if these hold arboviruses.
This Phase 2 project will re-configure and metric the Phase 1 innovations to allow them, in Phase 3, to be
placed on Moskeet in two operational architectures (OA1 and OA2). A series of improvement and adaptations
will be evaluated using tightly crafted metrics in two Aims. Meeting these metrica will trigger a commitment by
TrakITNow to support Phase 3 funding to launch a combined product,
Aim 1 will develop and metric Firebird's chemistry for an OA1 architecture that will convert Moskeet from a
trap-count-speciate-communicate product into a trap-count-speciate-sample-communicate product. This will
exploit Firebird's Phase 1 innovation (SterileQTM) that autonomously traps and stabilizes viral RNA. Different
baits, RNA-stabilizing preservatives, and pre-amplification enzymes will be metricked to create, at the end of
Year 1, a Moskeet-ready OA1 chemistry that allows continuous sampling of mosquitoes. Metrics include (a)
>50% of infected mosquitoes leaving detectable sample, (b) >200 hours half-life of RNA, and (c) capture of >1
pg of RNA. An instrument from Insilixa (Hydra), also enhanced by Firebird's reagents, will be used for on-site
virus detection. Hydra is portable, and its low complexity design allows it to be used by amateurs.
Aim 2 will develop and metric Firebird's chemistry for an OA2 architecture. This will convert Moskeet into a
trap-count-speciate-sample-analyze-communicate product. Here, we will develop and benchmark point-of-
sampling amplification tools, specifically: (a) RT-PCR, and (b) loop amplification (LAMP). These will, as
needed, incorporate reagent innovations (AEGIS, SAMRS, Biversals) to support highly multiplexed detection of
arboviruses, create uniform amplification of multiple analytes, manage primer-primer products, prevent loss of
PCR resources to off-target processes that create "monsters", and manage arbovirus sequence divergence.

Public health relevance
Field Detection of arboviruses directly from mosquito traps Firebird Biomolecular Sciences, LLC. Narrative The NCEZID noted that "each year, scientists discover about two new mosquito-transmitted viruses that can make people sick." It therefore seeks small businesses to deliver products that survey environments for these viruses in multiplexed and flexible ways. In addition to supporting public heath efforts to predict and manage disease outbreaks, surveillance ensures that before damages are caused by spraying, some benefit is likely to emerge. Thus the CDC, the EPA, and their counterparts overseas all strongly recommend comprehensive mosquito surveillance; Florida law requires it before spraying. Phase 1 results have attracted the attention of the instrument-maker TrakitNow, whose award winning Moskeet platform counts and speciates mosquitoes, incorporates multiple information sources such as weather to guide PHS response, interacts with social networks, and does everything except extract a sample from potentially infected mosquitoes and examine it for viruses. If successful, this project will complete this surveillance platform, allowing PHS and private entities to move smoothly from the trapping of mosquitoes through to reporting of presence of mosquito-borne pathogens over times ranging from days to weeks, either under an operational architecture where an attendant visits a trap and PCR amplifies the trapped viral RNA (e.g., using an Insilixa device, operational architecture 1, OA1) or robotically performs those amplification (operational architecture 2, OA2).